An ASD Enriched Risk (ASD-ER) ECHO Cohort

Autism spectrum disorders (ASD) are characterized by early-emerging impairment in social interaction and
communication in the presence of restricted and stereotyped interests or behaviors. The prevalence of ASD in
the US is approximately 1.5%, making it the most common serious neurodevelopmental condition, and annual
costs associated with ASD in the US exceed $250 billion.2 Child neurodevelopment is a priority outcome for
the ECHO initiative and ASDs clearly are a neurodevelopmental outcome of major public health concern.
While genetic factors are known to influence ASD risk, the underlying mechanisms are quite complex, and
multiple lines of evidence suggest a role for environmental risk factors. Approximately 20% of siblings of
children with ASD will develop ASD themselves and up to 40% of ASD siblings will show signs of some type of
atypical neurodevelopment. This lends obvious support to the role of genetic susceptibility in ASD but also
reveals how siblings of children with ASD, whose genetic backgrounds are likely enriched with low-to-moderate
frequency ASD risk genotypes, form a strong candidate population in which to investigate candidate ASD
environmental factors that likely interact with genetic susceptibility. It has long been known that toxic
chemicals affect brain development even at low levels – with fetal development being a window of particular
vulnerability. Here we propose to assemble an ECHO pediatric cohort-of-cohorts (referred to as the ASD-ER
cohort) comprised of 1,713 siblings of children with ASD who have taken part in five research studies at 14
sites. ASD-ER will be used to investigate environmental risk factors for ASD and to contribute to the broader
mission of the ECHO initiative. We will collect shed deciduous teeth from children and employ recently
emerging technologies that enable temporally resolved quantification of persistent organic pollutants and
metals in tooth biosamples. These exposure data will be used in both frequentist and Bayesian analytic
frameworks to estimate effects of prenatal exposure in different time windows on continuous, categorical, and
trajectory ASD-related outcomes. Child genetic susceptibility will be incorporated into our analyses through the
development and application of ASD- and exposure-specific genetic risk scores in order to maximize our ability
to detect risk due to prenatal POP and metal exposure. Then, because including ASD-ER subjects in ECHO
will also shift, and enrich the right tail of, dimensional ASD-related neurodevelopmental trait distributions in the
ECHO study population, we advocate for capitalizing on this by conducting a gene-environment wide
interaction study (GWIS) for ASD and related-outcomes in the full ECHO cohort and outline an approach for
implementing this. The unique features of ASD-ER (the enriched risk nature of the cohort combined with the
availability of already-completed deep neurodevelopmental phenotyping on all subjects and readily available
genomic data plus a wide range of banked prenatal biosamples on subgroup) overlaid with the scale of the
larger ECHO effort, can combine to numerous opportunities for truly innovative science.

Public health relevance
PROJECT NARRATIVE Neurodevelopment is a major focus area for the ECHO initiative and autism spectrum disorders (ASD) are a neurodevelopmental outcome of major public health significance. Here we bring together a large sample of children whose other siblings have ASD and who have participated in other research projects so that we can collect additional data from them as part of ECHO in order to determine whether prenatal exposure to persistent organic pollutants and metals affects risk of ASD-related outcomes. We will also investigate whether genetic background makes some children more or less susceptible to these exposures and by doing this will demonstrate model approaches for studying gene-environment interaction that can be adapted to other exposures and outcomes in ECHO.